Notch signaling pathways in auditory support cell differentiation and maintenance

DESCRIPTION (provided by applicant): In humans and other mammalian species, damage to mechano-sensory hair cells is irreversible, leading to deafness and balance disorders. Remarkably, non-mammalian vertebrates regenerate lost hair cells. In birds, supporting cells have been shown to replace lost hair cells by mechanisms involving either cell division or direct trans-differentiation. In the mammalian auditory sensory organ, supporting cells do not regenerate lost hair cells. Strikingly, our findings suggest that mammalian supporting cells retain the intrinsic ability to function as hair cell progenitors, but their plasticity to regenerate hair cells is actively suppressed by external inhibitory cues. Our long-term goal is to utilize the latent plasticity of supporting cells to develop supporting cell based hair cell replacement strategies. To attain this goal, it is vital to improve our knowledge of the molecular programs active in developing and in mature supporting cells. We reason that to reprogram and induce de- differentiation of supporting cells and consequently trans-differentiation of supporting cells into hair cells, we first have to understand the signals that control differentiation and maintenance in the supporting cell lineage. The goal of this proposal is to determine if the Notch signaling pathway, an evolutionary ancient and highly conserved cell-to-cell communication mechanism, functions in supporting cell differentiation and cell maintenance. In Specific Aim 1 of our proposal, we will test if Notch signaling plays an instructive role in supporting cell differentiation. We will test if induction of an activated form of the Notch1 receptor is sufficient to induce supporting cell fate and whether inhibition of Notch signaling with 3-secretase inhibitors effects the onset and progression of supporting cell differentiation. In Specific Aim 2 of our proposal, we will ablate Rbpj, a core component of the canonical Notch signaling pathway, in supporting cells to address if Notch signaling is required for supporting cell maintenance in the intact and hair cell damaged cochlea. To do so we will employ Rbpj conditional mouse mutants in combination with tamoxifen inducible CreERT lines. We anticipate that this analysis will provide valuable insight into the molecular mechanisms that drive supporting cell differentiation and elucidate the function of Notch signaling in supporting cell maintenance in the adult cochlea. In parallel, we will address a longstanding question-does persistence of Notch signaling in the hair cell damaged cochlea underlie the lack of hair cell regeneration in mammals? Addressing this question is relevant to human health as inhibiting Notch signaling using 3-secretase inhibitors in mature cochlea could provide a means for restoring a latent capacity to regenerate hair cells. PUBLIC HEALTH RELEVANCE: It is believed that lack of hair cell regeneration in mammals is due to an inability of neighboring supporting cells to regenerate damaged hair cells. In our proposal, we will characterize the molecular mechanisms instructing supporting cell differentiation and maintenance to elucidate why supporting cells fail to de-differentiate and regenerate lost hair cells. We believe that our findings will shed light on the molecular machinery that restrict hair cell regeneration and could provide new targets for future hair cell replacement therapies.

Public health relevance
Project narrative: It is believed that lack of hair cell regeneration in mammals is due to an inability of neighboring supporting cells to regenerate damaged hair cells. In our proposal, we will characterize the molecular mechanisms instructing supporting cell differentiation and maintenance to elucidate why supporting cells fail to de-differentiate and regenerate lost hair cells. We believe that our findings will shed light on the molecular machinery that restrict hair cell regeneration and could provide new targets for future hair cell replacement therapies.